A microfluidic-enabled SmartPlate for precision culture, control and monitoring of living cells. NAICS 5417715 PSC AN12 Contractor DUNS 078744267

The use of advanced cell-based disease models and long-term live cell assays in drug discovery is increasing rapidly. Maintaining these cellular systems in industry standard multiwell plates typically relies on repeated cumbersome and time-consuming visual inspections and manual media exchanges. New approaches to enable the efficient monitoring and manipulation of cell cultures in multiwell plates over a period of several weeks are therefore needed.